TGF-Beta Regulates CFTR-Mediated Airway Smooth Muscle Dysfunction

PROJECT SUMMARY/ABSTRACT
Cystic fibrosis (CF) is a lethal genetic disorder characterized by progressive lung disease and airway obstruction.
CF is caused by mutations in the CF transmembrane conductance regulator (CFTR). Patients with CF often
develop airway hyperresponsiveness (AHR) related to smooth muscle dysfunction, which worsens airway
obstruction and portends faster lung function decline. TGF is a genetic modifier of CF, with higher TGF levels
linked to more severe lung disease. TGF also causes worse AHR and smooth muscle abnormalities in CF mice
versus non-CF mice. It is unknown how TGF modifies CF lung disease or drives CF smooth muscle dysfunction.
This proposal seeks to investigate TGF’s role in CF airway smooth muscle dysfunction. Currently, no therapies
directly target smooth muscle abnormalities or TGF signaling in CF. This proposal investigates the overall
hypothesis that TGF regulates CFTR-mediated airway smooth muscle dysfunction through effects on both CF
epithelial and smooth muscle cells. CF animal and mouse/human primary cell culture models will be used to test
the tissue specific function of CFTR in TGF induced lung disease. Aim 1 will determine the role of CFTR
dysfunction in airway epithelial cells in mediating TGF-driven lung disease, using TGF exposed epithelial-
specific Cftr knockout mice and primary murine and human cell culture models. These studies will focus on
epithelial and inflammatory mediators. Aim 2 will test the mechanisms of TGF-induced CF airway smooth
muscle dysfunction by examining pulmonary and smooth muscle abnormalities in both smooth muscle-specific
Cftr knockout mice and isolated murine and human CF cell culture models. Tests of TGF-mediated AHR, lung
function, and smooth muscle contractility will be used to compare CF and non-CF airway smooth muscle function.
The PI for this proposal, Dr. Elizabeth Kramer, is a physician scientist in Pulmonary Medicine with a focus on
drivers of early CF lung disease. She has a Ph.D. in Molecular and Developmental Biology and an extensive
background in mouse models and lung physiology. Her mentors provide complimentary expertise in CF mouse
and cell culture models (Dr. A.P. Naren, primary mentor), translational CF research and personalized medicine
(Dr. J.P. Clancy, Co-mentor), and translational research design (Dr. Raouf Amin, Co-mentor). These mentors
have an established record of success in mentoring academic scientists. They are personally committed to Dr.
Kramer’s success in completing this proposal and transitioning to an independent research career.
The training plan outlined in this application will provide the applicant with crucial training in innovative laboratory
techniques, cutting-edge bioinformatics analysis, immunology, and advanced career skills to successfully
establish an independent translational science program. This training plan capitalizes on the excellent
environment and support at Cincinnati Children’s Hospital. Addressing these training goals and completing the
studies described in this application will build upon Dr. Kramer’s prior expertise in molecular and developmental
biology, providing a solid scientific and training platform to launch her independent research career.

Public health relevance
PROJECT NARRATIVE Despite advances in therapy, people with cystic fibrosis (CF) develop progressive airway obstruction that is worsened by airway smooth muscle dysfunction. In this proposal, we will study how the CF disease modifier TGF drives CF lung disease through airway smooth muscle dysfunction and define its mechanism of action. These results will directly improve our understanding of CF obstructive airway disease and identify novel therapeutic targets to improve the health of children with CF.